The Role of Microglia in Neuroblast Migration in the Olfactory System

Not Applicable – This is a request for an extension.

Public health relevance
Not Applicable – This is a request for an extension.